Eighteenth Forum on Osteoporosis and Metabolic Bone Diseases for Fellows in Training

This application seeks support for the 18th Fellows Forum on Osteoporosis and
Metabolic Bone Diseases. The conference will be held September 25-26, 2024,
immediately prior to the Annual Meeting of the American Society of Bone and Mineral
Research in the Toronto Convention Center, Toronto, Canada. It will be a live, in-person
event. We expect to have approximately 50 postdoctoral trainees who are united by their
research interests but who are training in a number of different basic and clinical
specialties. The faculty will consist of 12 of the most highly valued thought leaders in the
world. The ability of young investigators with promise to interact with this faculty in a
setting of both didactic and interactive workshops has been and will continue to be a
seminal experience, leading to a further commitment on the part of these fellows to train
in osteoporosis and other metabolic bone diseases.

Public health relevance
The application seeks support for the 18h Fellows Forum on Osteoporosis and Metabolic Bone Diseases that will be held at the Toronto Convention Center, Toronto, Canada, September 25-26, 2024